Variant to Function Mapping of B-ALL Risk Loci

ABSTRACT
Acute lymphoblastic leukemia (ALL) is the most common childhood malignancy and arises predominantly from
developing B-cell precursors. B-cell ALL (B-ALL) remains a leading cause of cancer-related mortality in children,
and B-ALL survivors face long-term therapy-related morbidities. Moreover, B-ALL disproportionately impacts
children of Hispanic/Latino ethnicity, who have the highest risk of disease and inferior patient outcomes
compared to non-Hispanic white children. Prevention of B-ALL remains an essential goal, to mitigate childhood
mortality and suffering and to reduce disparities, and this necessitates an understanding of the disease’s root
causes. Paramount to this will be elucidating the mechanisms of genetic predisposition to B-ALL. Previous
genome-wide association studies (GWAS) have identified at least 15 risk loci associated with childhood B-ALL,
but in most cases the causal variants have not been identified. Our proposal aims to integrate results from a
large multi-ancestry GWAS of childhood ALL with single-cell epigenomic data followed by targeted base editing
in hematopoietic stem and progenitor cells (HSPCs), to pinpoint causal variants and discern their impact on
normal human B cell development. Through this innovative and collaborative approach, we hypothesize that we
will uncover mechanistic insights into the root causes of B-ALL development that could inform future preventive
strategies. In our first aim, we will conduct a multi-ancestry GWAS followed by statistical fine-mapping analysis
of known B-ALL risk loci using existing genotype data. These results will be integrated with single-cell accessible
chromatin data spanning human hematopoiesis and B cell development using the SCAVENGE method we have
developed previously, to identify specific B cell developmental stages that underlie B-ALL predisposition and to
identify causal variants at each B-ALL risk locus. In our second aim, we will generate new single-cell multi-omic
data, including from joint scRNA- and scATAC-seq in single cells, from human HSPCs undergoing B cell
differentiation in vitro. These data will enable regulatory mapping in cells across B cell development, including
rare intermediate cells, and will be used to map relevant cell states and target genes for the fine-mapped B-ALL
risk variants. Finally, in our third aim, we will investigate the functional impact of B-ALL risk variants using genome
editing. We will prioritize six causal variants from our other mapping approaches, including variants in ARID5B
and GATA3 that have previously been identified as causal and that contribute to the increased B-ALL risk in
Hispanic/Latino children. We will recreate these six variants individually and in specific combinations via base
editing in human HSPCs from multiple donors that will then be subject to B cell differentiation and investigate
their effects on B cell development and on illegitimate V(D)J recombination, a known driver of B-cell
leukemogenesis. Our innovative variant-to-function mapping approach will reveal the precise mechanisms
through which B-ALL association loci may increase a child’s risk of developing leukemia and may highlight novel
therapeutic targets and inform future approaches for childhood leukemia prevention.

Public health relevance
PROJECT NARRATIVE B-cell acute lymphoblastic leukemia (B-ALL) remains a leading cause of childhood morbidity and mortality, and a full understanding of how this disease develops is lacking. In this study, we will integrate genetic epidemiology with innovative functional genomic approaches to determine the mechanisms through which germline genetic risk variants associated with B-ALL can impact B cell development and leukemogenic processes. Our unique approach will reveal novel insights into the etiology of B-ALL and may inform targeted therapeutic and preventive strategies.